Intrinsically Disordered Protein Structural Dynamics from Combined Solution and Gas-Phase Approaches

PROJECT SUMMARY
Intrinsically disordered proteins (IDPs), proteins that do not assume a preferred folded conformation in
solution, make up around one-third of the entire human proteome, and their misfolding is a causative agent of
several serious diseases. Although an array of biophysical tools has been applied to the structural analysis of
IDPs, there is still a significant gap between the need to accurately measure IDP structures and the available
tools. Current tools provide either not enough information content to gain significant insight on the many IDP
structures present in the overall ensemble or can only provide an ensemble average due to interconversion of
conformations over the time frame of the experiment. Therefore, the goal of this application is to apply native ion
mobility/mass spectrometry (IM/MS) tools developed in the Webb laboratory for analyzing well-folded proteins
in combination with molecular dynamics to characterize the structural ensembles of IDPs and intrinsically
disordered regions (IDRs) with conformational and proteoform specificity and to determine the effect on those
structural ensembles of post-translational modifications (PTMs).
The proposed work in this application is expected to answer the following biological questions: 1.) What
are the IDP conformations in the overall ensemble? Crosslinked and labeled IDPs/IDRs will be identified
under native-like conditions to determine structural ensembles as a function of solution conformation (by IM and
MS). Crosslinking/labeling identifications will be used to determine structural ensembles of IDPs/IDRs with
molecular dynamics. 2.) How do post translational modifications and ligand binding affect IDP structure?
These methods will be used to measure how PTMs and small molecule binding affects conformational
ensembles of IDPs, linking structural changes to their functions and to aggregation. 3.) Which conformational
states and proteoforms of histones bind epigenetic partners? Histone tails are IDRs decorated with many
combinations of PTMs that regulate access to DNA. We will use our tools on individual histones, on the intact
nucleosome, and on nucleosomes upon binding modifier and reader proteins to measure changes in structural
ensembles.
This research represents a substantive departure from the status quo by using a combined solution
(crosslinking and labeling) and gas-phase MS structural toolkit to provide structural details of IDPs/IDRs
measured independently by proteoform and conformation. The research is significant because it is expected to
bridge the gap between the tools available for the conformational study of IDPs and the fundamental and
biomedical need to characterize their structures. Ultimately, IDP conformational characterization is likely to lead
to a much broader understanding of cellular biology and the importance of IDPs/IDRs as interaction hubs and
regulators and a better understanding of their roles in disease and treatment.

Public health relevance
PROJECT NARRATIVE The proposed research represents a new and alternative strategy for characterizing important structural parameters of disordered proteins, proteins with intrinsically disordered regions, and mixtures of disordered proteins, all of which are critical for cellular function and are implicated in many degenerative disorders and epigenetic diseases. Disorder makes these proteins difficult to characterize structurally, and existing methods for analyzing them are unable to separately analyze mixtures of disordered proteins often found in cells. Thus, the proposed research is relevant to the NIH mission as it contributes to the fundamental knowledge of human molecular biology and is relevant for its application in reducing illness in patients with neurodegenerative disorders and epigenetic diseases.